Depression and Insulin Resistance in Adolescents

PROJECT SUMMARY/ABSTRACT Type 2 diabetes (T2D) is a chronic disease accompanied by heightened risk for severe health complications such as cardiovascular and peripheral vascular disease, stroke, blindness, and renal failure. The alarming rise in the manifestation of T2D among adolescents and young adults poses an enormous public health burden. Insulin resistance (IR) is a major physiological precursor to T2D. Thus, prevention efforts targeting modifiable risk factors for IR have the potential to diminish the risk of developing T2D significantly. Depressive symptoms often first appear during adolescence, are associated with IR in adolescents and adults, predict adult-onset T2D, and contribute to increased risk for T2D mortality and morbidity, beyond the interrelationship of depression with obesity. The mechanisms underlying the link between depressive symptoms and IR are unclear. Depressive symptoms theoretically induce IR by promoting stress-induced behaviors (altered eating, lowered fitness) and upregulating physiological stress mechanisms (cortisol, neuropeptide Y). Psychotherapy for depression improves IR in adults, but it is uncertain whether ameliorating depressive symptoms prevents progression of IR in adolescents at risk for T2D. The aims of this proposal are: 1) to assess the effects of a 6-wk cognitive-behavioral (CB) depression prevention group vs. a 6-wk standard-of-care health education (HE) group on reducing depressive symptoms and improving IR in adolescent girls at risk for T2D; 2) to assess the stress-related behavioral and physiological factors that mediate the relationship underlying decreases in depressive symptoms and improvements in IR; and 3) to pilot delivery of a mindfulness-based stress reduction (MBSR) group to adolescents girls at risk for T2D. The PI, Dr. Lauren Shomaker, is a child clinical psychologist whose background in adolescent development/psychopathology, eating behavior, and pediatric obesity/obesity- related health co-morbidities is uniquely suited to advance the aims in this proposal. During the K99 phase, Dr. Shomaker will obtain training to enhance her expertise in: 1) conduct of randomized controlled trials (RCTs) in adolescents, ii) measurement of IR, and iii) assessment of cardiovascular fitness. Dr. Shomaker has assembled a strong mentoring and consultant team with expertise in RCTs for pediatric obesity and IR (Co- Mentors: Marian Tanofsy-Kraff, PhD, Jack Yanovski, MD, PhD), CB depression interventions (Eric Stice, PhD, Marjan Holloway, PhD), cardiovascular fitness (Kong Chen, PhD), stress physiology (Zofia Zukowska, MD, PhD), advanced statistical analysis (Cara Olsen, PhD), and MBSR (Kirk Brown, PhD). The proposed K99/R00 application is the ideal vehicle to promote Dr. Shomaker's ultimate goal of transitioning to an independent career focused upon the interconnections between adolescent psychosocial development and physical health, and the putative mechanisms underlying the links between psychosocial factors and physical well-being.

Public health relevance
PROJECT NARRATIVE Type 2 diabetes (T2D) is one of our nation's most common chronic diseases. It affects >7.8% of the U.S., and the societal cost is >$90 billion/yr. In the past, T2D was considered a disease limited to older adults. Yet, there has been an alarming rise in its manifestation among adolescents and young adults. Early onset T2D has been associated with greater risk of end-stage renal disease and death and a shorter life expectancy of 15-27 yrs. Insulin resistance (IR) is a major physiological precursor to T2D. The normative rise in IR that characterizes puberty may render adolescence a sensitive period, triggering the progression of worsening IR among adolescents at risk for T2D. Adolescence also marks a peak period for the onset of elevated depressive symptoms among girls. Elevated depressive symptoms affect over 25% of adolescents. Even in the absence of full criteria for major depressive disorder (MDD), adolescent depressive symptoms are associated with considerable psychosocial and behavioral impairment and a 2-4-fold greater risk of developing MDD. Depressive symptoms also are associated with IR in adolescents and adults and predict T2D onset. Therefore, amelioration of elevated depressive symptoms in adolescent girls who are at risk for T2D has the potential to improve IR and risk for T2D in a considerable subset of youth. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Insulin resistance (IR), in conjunction with impaired insulin secretion, is the major physiological precursor to type 2 diabetes (T2D). T2D is a chronic disease accompanied by heightened risk for severe health complications including cardiovascular and peripheral vascular disease as well as stroke, blindness, renal failure, and amputations. Over the past four decades, the three-fold increase in T2D prevalence in adults and the alarming rise in its manifestation among adolescents have paralleled the dramatic nationwide increase in obesity. IR typically develops through gain of excess body fat. Accordingly, adolescent obesity status (body mass index, kg/m2 e95th%ile), particularly when found in conjunction with a family history of T2D, is associated with greater IR and is a prospective risk factor for acquiring T2D. T2D is preventable. Prevention centers upon improving IR. Adolescent prevention programs for T2D typically have involved intensive lifestyle interventions aimed at improving IR through weight loss. There have been some positive short-term effects on adolescent IR achieved via weight reduction. However, results do not persist, despite the time, cost, and extraordinary effort of such programs. Consequently, innovative programs targeting modifiable, novel risk factors for IR independent of weight loss are warranted. Evidence suggests that depressive symptoms are associated with IR in adults and adolescents. Depressive symptoms theoretically play a role in the etiology and pathogenesis of T2D; depression precedes and predicts adult-onset T2D and contributes to increased risk for T2D mortality and morbidity. Depressive symptoms are hypothesized to affect IR by promoting stress-induced behaviors such as disinhibited eating and lowered cardiovascular fitness, and upregulating physiological stress mechanisms such as cortisol and neuropeptide Y (NPY; FIGURE 1). The increases in depressive symptoms and IR observed during female pubertal development make adolescence an ideal period to understand mechanisms underlying the depression-IR relationship and to intervene with depression to improve IR. Notably, psychotherapy treatment for major depressive disorder among adults with and without T2D improves IR. However, it is unknown whether ameliorating adolescent depressive symptoms affects IR, a primary physiological antecedent of T2D. We therefore propose an innovative randomized controlled clinical trial designed to improve IR among obese adolescent girls with elevated depressive symptoms. We will determine and compare the effects of FIGURE 1. Stress-induced theoretical model of depressive symptoms' impact on insulin i) a 6-wk cognitive-behavioral group intervention shown to be resistance. e=measurement error. efficacious in preventing depression with ii) a 6-wk standard-of-care health education group program. The primary outcome will be IR. We also will measure: a) depressive symptoms, b) eating behavior, c) cardiovascular fitness, d) stress biomarkers, and e) body composition. Specific aims are: Aim 1: To assess the effects of a 6-wk cognitive-behavioral (CB) group intervention compared to a 6- wk standard-of-care health education (HE) control group in 116 obese adolescent girls with elevated depressive symptoms and a family history of T2D. Hypothesis 1: In comparison to the control group, the CB group will (1a) decrease depressive symptoms and (1b) improve IR at post-intervention and over the course of a 12-mo follow-up interval. Aim 2: To assess stress-related behavioral and physiological mediators underlying the relationship between decreases in depressive symptoms and improvements in IR. Hypothesis 2: Mediators of the relationship between depressive symptoms and IR at post-intervention and over the course of a 12-mo follow-up interval will include: a) Decreases in disinhibited eating b) Increases in cardiovascular fitness c) Decreases in cortisol d) Decreases in NPY Aim 3: To pilot the feasibility and acceptability of a mindfulness-based stress reduction (MBSR) group, a potentially valuable alternative to CB, in 40 obese adolescent girls with elevated depressive symptoms and a family history of T2D. Hypothesis 3: Relative to a CB group intervention, MBSR will be feasible and acceptable.